Circadian regulation of dopamine 1 receptor signaling in the Nucleus Accumbens

PROJECT SUMMARY
Nucleus Accumbens (NAc) activity is critically important for response to motivated stimuli, including
aversive stimuli. However, it is not known how the NAc processes and responds to these stimuli across the 24hrs
cycle. We and others have found NAc shows daily changes in neuronal activity which appears to be in phase
with circadian-dependent dopamine release from the primary dopamine input to the NAc, the ventral tegmental
area (VTA). Therefore, response to motivated stimuli may vary depending on time-of-day. We recently
discovered the circadian gene CRYPTOCHROME (CRY) modulates Gs-protein coupled with dopamine 1 (D1)
receptor which may alter neuronal activity and excitability of NAc projection neurons. These data suggest
circadian regulation of dopamine receptor activity in the NAc has the ability to strongly alter response to
dopamine driven by aversive stimuli via the dopamine 1 receptor. We hypothesize that CRY controls circadian
NAc activity through modulation of dopamine 1 receptor function.
In year 1 of this proposal, we will assess the role of CRY in regulating circadian dopamine 1 receptor
function ex vivo and in vivo. We will selective knockdown CRYs in the NAc and assess D1 receptor function by
whole-cell patch clamp physiology by monitoring voltage-gated K+ currents ex vivo and by fiber photometry to
monitor D1 receptor signal transduction dynamics in vivo. In year 2, we will use ex vivo approaches with selective
knockdown of CRYs to assess DA-dependent NAc excitability. We will further determine circadian-dependent
VTA dopamine release and NAc neuronal activity changes in response to aversive stimuli in vivo by monitoring
calcium signaling with fiber photometry. This study will allow us to dissect mechanistic, circadian regulation of
NAc neurophysiological response and dopamine receptor function. The overall aim of this project is to determine
the role of CRY in regulating excitability and function of the NAc and how this regulation controls NAc response
to aversive stimuli. This proposal will provide translationally relevant information about circadian regulation of
basic mechanistic underpinnings of NAc dopamine function and behaviorally relevant, neurobiological response
to aversive stimuli. This work will further provide a foundation for understanding how circadian-driven NAc
changes underlie susceptibility to mood disorders such as depression.

Public health relevance
PROJECT NARRATIVE Circadian-driven clock genes cause time-of-day dependent changes in dopamine release and dopamine receptor activity in the Nucleus Accumbens. Changes in Nucleus Accumbens activity are known to alter response to stressful, aversive stimuli. Using ex vivo and in vivo approaches, we aim to assess how circadian- driven changes in the clock gene expression alter Nucleus Accumbens neuronal physiology through the dopamine 1 receptor and determine how these fluctuations vary neurobiological response to aversive stimuli.